GROWTH FACTORS ON PERIODONTAL WOUND HEALING AND REGENERATION

The regulation of wound healing is a complex mechanism involving cell proliferation, chemotaxis, and differentiation. The effects of growth factors on these cell functions support their role in wound healing, including periodontal healing. The exogenous addition of growth factors has been shown to enhance the regenerative capacity of the periodontium. Regeneration of the periodontal attachment apparatus requires the involvement of periodontal ligament (PDL) cells. Human PDL fibroblasts will be cultured in vitro to investigate the cellular basis for the involvement of the PDGF isoforms, and TGF-b1 in periodontal wound healing and regeneration. To achieve this objective, mitogenic assays will be used to quantitate the effects of PDGF-AA and -BB, and TGF-b on DNA synthesis. Additionally, the regulating effects of TGF-b1 on the biologic activity of PDGF will be assessed. Northern and western blot analysis will be done to identify the modulation of PDGF transcripts, protein synthesis, and release. PDGF receptor transmodulation will be evaluated on a phenotypic level with radioreceptor assays using 125l-labeled PDGF and on a transciptional level using northern blots. This study will determine the modulating effects of the polypeptide growth factors. PDGF-AA and -BB, and TGF-b; and contribute to the understanding of PDL cell-cytokine interactions in the regeneration of the periodontium.